Intracerebroventricular (ICV) Administration of CD19-Targeting Chimeric Antigen Receptor (CAR) T cells for Treatment of Primary Central Nervous System Lymphoma

PROJECT SUMMARY
Primary central nervous system lymphoma (PCNSL) is a rare hematologic maligancy in which non-Hodgkin
lymphoma (NHL) initially presents in the central nervous system (CNS). Therapeutic options for PCNSL are
limited; standard of care high-dose methotrexate-containing regimens have been unchanged for over 40 years,
and are not curative in most patients. Chimeric antigen receptor (CAR) T cell therapy targeting CD19 (CD19-
CAR T cells) is a powerful form of immunotherapy that has an established safety profile when delivered
intravenously (IV) to treat patients with NHL. Our clinical platform for manufacturing CD19-CAR T cells at City of
Hope (COH) has been evaluated in a series of phase 1 clinical trials for B cell acute lymphoblastic leukemia
(ALL) and for NHL. To date, all previous and ongoing CD19-CAR T cell trials have infused the CAR T cell product
IV. We have preliminary evidence that IV-administered CD19-CAR T cells can be detected in the CNS and have
anti-tumor activity in treating patients with PCNSL. However, the efficacy of IV CAR T cell therapies for patients
with PCNSL is limited, possibly due to poor trafficking of CAR T cells from blood to CNS that may result in
reduced activity against PCNSL compared to systemic NHL. In phase 1 trials at COH, locoregional delivery of
CAR T cells to treat CNS malignancies such as glioblastoma has led to improved outcomes. Studies in our
animal models show improved disease response, durability and resistence to tumor rechallenge using
intracerebroventricular (ICV)- vs IV- delivered CD19-CAR T cells in xenograft mouse models of CNS lymphoma.
Thus, to optimize the efficacy of CD19-CAR T cells and improve the outcomes of patients with PCNSL, we
propose to administer CD19-CAR T cells via ICV delivery. We hypothesize that ICV-delivered CD19-CAR T
cells will be safe and demonstrate high anti-PCNSL activity. In Specific Aim 1, we will conduct a phase 1 clinical
trial to assess the safety and activity, and determine the recommended phase 2 dose (RP2D) of ICV delivered
CD19-CAR T cells in participants with PCNSL. In Specific Aim 2, we will conduct a series of correlative studies
to assess mechanisms of toxicity, CAR T cell persistance, trafficking to the peripheral blood, immune cell
phenotype, and effect on tumor. We plan to examine the effects of ICV-delivered CAR T cells on normal CD19+
B cells in the peripheral blood to determine whether CAR T cells traffic from the CNS to the blood, as we expect
based on our preclinical animal models of PCNSL. Activity against normal B cells in the blood would indicate
that ICV delivery could be a viable treatment option for patients with secondary CNS lymphoma, who have both
CNS and systemic disease. Successful completion of the proposed clinical trial and correlative studies will
expand therapeutic options for patients with PCNSL and could inform the design of a potential subsequent clinical
trial to evaluate the safety and efficacy of treating patients with secondary CNS lymphoma.

Public health relevance
PROJECT NARRATIVE This proposal examines the safety and anti-tumor activity of CD19-directed chimeric antigen receptor (CD19- CAR) T cell immunotherapy for the treatment of primary central nervous system lymphoma (PCNSL). In this study, the CD19-CAR T cells will be delivered directly to the CNS by injection into the brain ventricle. The proposed clinical trial aims to give us a better understanding of CD19-CAR T cell activity following brain infusion, with the goal of improving the very poor outcomes of patients with PCNSL.